DELINEATING THE ROLE OF THE HOMOCYSTEINE-FOLATE-THYMIDYLATE SYNTHASE AXIS AND URACIL ACCUMULATION IN AFRICAN AMERICAN PROSTATE TUMORS

African American prostate cancer patients are known to be diagnosed at an earlier age, present with aggressive
disease, and are twice as likely to succumb to prostate cancer than other demographic groups. Despite a major
focus on socioeconomic factors, recent findings strongly argue for the existence of biological factors driving
cancer disparities. In my efforts to understand biological drivers in prostate cancer, I applied a novel DNA
damage detection method, Repair Assisted Damage Detection (RADD), and established that African American
tumors have more DNA lesions overall than EA tumors, especially uracil lesions. Our lab has previously
demonstrated that the homocysteine-methionine pathway is a metabolic hallmark of African American prostate
cancers, which fuels the progression of the folate cycle that is required for the conversion of deoxyuridine
monophosphate (dUMP) to deoxythymidine monophosphate (dTMP). An upregulation of metabolites in the de
novo pyrimidine biosynthesis pathway and altered levels of folate cycle metabolites were identified in African
American prostate tumors, suggesting the link between uracil metabolism and uracil lesion accumulation. Uracil
lesions are repaired by the base excision repair pathway. We have also shown that expression of XRCC1, a
protein involved in coordinating base excision repair function, was lower in African American prostate tumors,
indicative of defective base excision repair. These data collectively suggest that African American tumors exhibit
the consequences of thymidylate stress, where the ability of thymidylate synthase (TYMS) to convert dUMP to
dTMP is obstructed, resulting in dysregulation of base excision through the retention of uracil lesions. The
increased amounts of uracil lesions in African American men could be a cumulative result of changes in
nucleotide metabolism, which is caused by altered levels of components in the folate cycle and one-carbon
metabolism. These components, such Vitamin B12 and folate, are known to be reduced in African American
men, which could result from either dietary deficiencies or due to an aberrant homocysteine-methionine cycle,
or both. While we understand the molecular consequences of reduced folate as it relates to uracil accumulation,
the circumstances surrounding the DNA damage response through the regulation of Vitamin B12 and folate is
currently unknown. The hypothesis of this proposal is that altered levels of Vitamin B12 and folate contribute to
thymidylate stress, resulting in base excision repair pathway dysfunction and promoting prostate cancer
progression in African American men. In this proposal, we will 1) determine the clinical relevance of
homocysteine, Vitamin B12, and folate with prostate cancer progression in African American men and 2)
elucidate the role of homocysteine, Vitamin B12, and folate regulation on TYMS function and base excision
repair in African American prostate cancer patients. Successful completion of these aims will establish a link
between metabolism and DNA repair in African American men with prostate cancer and help develop metabolic
biomarkers to stratify these patients for DNA repair inhibitor therapies.

Public health relevance
PROJECT NARRATIVE African American men are immensely affected by prostate cancer, often diagnosed at an earlier age and with advanced disease. Our work has established a link between metabolic rewiring and defects in the DNA damage response that drives biological disparities in African American prostate cancer patients. Findings from this study will identify metabolic underpinnings and provide a new avenue for biomarker development and targeted cancer therapeutics for African American men.